Determinants of Myeloid Clonal Evolution

PROJECT ABSTRACT
Clonal hematopoiesis is acquired with aging, and in some cases, precedes the onset of both myelodysplastic
and myeloproliferative disorders. However, the genetic drivers that underlie the evolution of clonal
hematopoiesis and the subsequent disease risk remain poorly understood. This proposal builds on generated
evidence showing that telomere length, a genetic and clinically available biomarker, predisposes to clonal
hematopoiesis in Mendelian syndromes. We have also found evidence for distinct clonal hematopoiesis
mutations that appear to differentially predispose to hypoplastic and myeloproliferative phenotypes. In this
application, we will examine the role of telomere length in driving clonal evolution with aging in well-
characterized cohorts including a Baltimore-based cohort of community-based women with a large African
American subset. Additionally, we will also examine the onset and prevalence of a novel clonal hematopoiesis
mutation in the telomerase reverse transcriptase gene that appears to be protective against myeloid
malignancies. This K08 grant application is supported by outstanding mentors and in a strong translational
environment at Johns Hopkins University School of Medicine with a detailed mentorship and training plan that
focuses on genetic epidemiology and computational biology skills. The knowledge has the potential to impact
current paradigms related to hematopoietic aging, myeloid clonal disease risk as well as novel biomarkers of
specific disease risk and progression.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndrome and myeloproliferative disorders currently affect over 400,000 individuals in the United States alone; they affect blood production and predispose to leukemia. Their onset is age-dependent but the genetic factors that determine their risk with aging is not understood. This proposal examines the role of acquired mutations in the blood with aging that promote and protect against the acquisition of these blood disorders with the goal of identifying new approaches to their early identification and prevention.